Structural Racism, Pharmacy Closures and Disparities in Medication Adherence Among Older Adult Medicare Part-D Beneficiaries

PROJECT SUMMARY
The objective of this project is to evaluate the impact of structural racism within Medicare Part-D policies and pharmacy
closures on racial/ethnic disparities in adherence to chronic medications among older adult Medicare Part-D beneficiaries.
Although ongoing efforts focus almost exclusively on addressing individual-level barriers to medication adherence, older
adult Black/Hispanic minorities encounter community-level barriers, including the geographic accessibility of pharmacies,
in adhering to their prescription medications not experienced by their White counterparts due to racial/ethnic residential
segregation. Pharmacy closures disproportionately affect segregated minority neighborhoods and worsen existing disparities
in the geographic accessibility of pharmacies. Medicare Part-D policies, including low pharmacy reimbursement rates and
the growth of preferred pharmacy networks that often exclude pharmacies located in minority neighborhoods, are considered
a fundamental cause of such closures. Despite these insights, the impact of closures on disparities in medication adherence,
and the role of structural racism within Part-D pharmacy access regulations, is not known. Pharmacy closures may be an
overlooked community-level mechanism of structural racism that exacerbates the adverse consequences of segregation on
disparities in pharmacy access and medication adherence. We propose to leverage several proprietary and public data
sources, including a census of Medicare Part-D patient-level prescription claims, to assemble a longitudinal, multi-level
geocoded dataset with detailed information on pharmacy locations and characteristics (e.g., preferred pharmacy status) and
derive a series of novel measures, including a multidimensional county-level measure of structural racism within Medicare
Part-D (e.g., ratio % of pharmacies located in Black vs. White communities that participate in Part-D preferred networks)
and conduct innovative analyses. The proposal aims to: (1) evaluate the effect of pharmacy closures on racial/ethnic
disparities in adherence to chronic medications among Medicare Part-D beneficiaries before (2014-2019) and during (2020-
2022) the COVID-19 pandemic; (2) Determine the extent to which individual-level (e.g., dual-eligible) and community-
level (e.g., racial/ethnic composition) characteristics modify the effect of pharmacy closures on disparities in adherence to
chronic medications among Medicare Part-D beneficiaries and identify subgroups most at-risk for non-adherence post-
closure and in need of pharmacy services; and (3) Investigate the impact of exposure to structural racism within Medicare
Part-D on medication adherence among Medicare Part-D beneficiaries by race/ethnicity at the individual-level and
community-level. Our proposed work is innovative because it will be the first study to investigate the impact of pharmacy
closures on persistent disparities in medication adherence at older ages. Our analyses of multi-level causal pathways
responsible for changes in medication adherence post-closure is also novel. With respect to expected outcomes, the work
proposed will contribute evidence that policymakers need to advance Medicare Part-D payment and delivery reforms that
reduce, and not worsen, disparities in pharmacy closures and, in turn, medication adherence. These outcomes will have a
positive impact given the increasingly important role of pharmacies in preventive and emergency care and will support NIA
in its strategic goals of informing policy decisions and reducing health disparities.

Public health relevance
NARRATIVE Despite evidence pharmacy closures disproportionately affect predominately Black and Hispanic neighborhoods, and Medicare Part-D policies and practices are a fundamental cause of such closures, the impact of pharmacy closures on persistent disparities in medication adherence among older adults is not known. The proposed project will evaluate the extent and impact of pharmacy closures on medication adherence among chronically ill Medicare Part-D beneficiaries and identify subgroups most at-risk for non-adherence post-closure. Our findings will contribute new evidence that policymakers need to advance equitable, and eliminate discriminatory, policies with Part-D and resolve persistent disparities in medication adherence.